Staged Low-Barrier and Mobile Care to Improve Retention and Viral Suppression in Hard-To-Reach Vulnerable People Living With HIV

Project Summary/Abstract
Existing HIV care systems in the United States, usually based on scheduled appointments, are often
inadequate for people living with HIV who have significant psychosocial and structural barriers to engagement
in care (i.e. homelessness/unstable housing, substance use disorders, severe mental illness). Rather than
connect these individuals to an incompatible system of HIV care, new approaches are needed that reduce
barriers to care engagement and offer increased flexibility. In this study, we seek to implement an evidence-
informed multicomponent clinical intervention that includes drop-in (i.e. no appointments) multidisciplinary HIV
primary care, mobile HIV care, staged escalation/de-escalation of care intensity as needed, and active referral
of patients from community-based clinical and non-clinical sites into this care model. This clinical intervention
will be implemented at four diverse care sites in San Francisco and Alameda counties, both priority
jurisdictions in the U.S. Ending the HIV Epidemic (EHE) strategy: an academic safety net HIV clinic, a needle
exchange program, and two federally qualified health centers. Eligibility criteria include: 1) current HIV viral
load ≥200 copies/mL or off antiretroviral therapy, 2) history of poor HIV care engagement, and 3)
homelessness/ unstable housing, any mental health disorder, or any illicit substance. We use the Consolidated
Framework for Implementation Research (CFIR) and RE-AIM implementation frameworks to guide
implementation strategy selection and our implementation and clinical effectiveness evaluation. In Aim 1, we
will use implementation mapping to assess barriers and facilitators of implementation and convene key
stakeholders to contextually integrate the clinical intervention and finalize the implementation strategies. In Aim
2, we will conduct a hybrid type 2 implementation-effectiveness study to evaluate the effect of clinical
intervention implementation on co-primary outcomes of Reach (any HIV primary care visit) and Effectiveness
(any HIV viral load <200 copies/mL) among patients referred to the care model over 12 months of follow-up
(n=400), comparing outcomes to two propensity score matched control groups (400 contemporaneous controls
identified using Department of Public Health data and 400 historical controls identified at study sites). We will
also assess clinic-level implementation outcomes. In Aim 3, we will evaluate and model the individual, clinic,
and population-level impacts of the intervention approach using heterogeneity and health equity analysis, cost/
cost-effectiveness analysis, scenario modeling of optimal and reduced component scenarios and population-
level impact. Our multidisciplinary study team has a strong track record of implementation research to improve
HIV care engagement among vulnerable populations. The proposed study will provide robust evidence for a
drop-in/mobile HIV care approach and strategies to support implementation at a diverse set of clinic sites. By
codifying these implementation strategies to facilitate wider-scale implementation, we seek to contribute to
improving EHE Treatment outcomes among those for whom traditional models of care are sub-optimal.

Public health relevance
Project Narrative Current HIV care models do not meet the needs of many people living with HIV (PLH), especially those who experience homelessness, mental illness, and substance use. This study will support the implementation and evaluation of an integrated comprehensive drop-in and mobile care approach for PLH who have challenges engaging in usual care. This care approach will be tested in four diverse care sites in San Francisco and Alameda counties (an academic safety-net HIV clinic, a syringe access site, and two federally qualified health centers).